MECHANISMS OF CHROMATIN STRUCTURE AND TRANSCRIPTION REGULATION BY THE NUCLEAR PORE COMPLEX

ABSTRACT
Nuclear structure-chromatin interactions underlie spatial genome organization and gene regulation during
development and disease. However, the mechanisms by which distinct nuclear structures control these
processes remain poorly defined. Understanding these mechanisms is critical, especially given that the
changes in the nuclear structure can propagate to alterations in cell signaling, cell division and genome
stability. The nuclear structure is in part composed of the nuclear pore complex (NPC) and lamina. Proteins
that are the building blocks of the NPCs, called Nucleoporins (Nups), have been implicated in transcription
and chromatin regulation by directly binding to chromatin. The NPC provides a nuclear compartment that
accommodates subnuclear organization of genes, transcription factors and chromatin regulatory proteins.
However, we still have very limited understanding on the molecular determinants and mechanisms of Nup-
mediated transcription and chromatin structure in mammalian cells, and how these processes are governed
during early development. Work to date suggests functional roles for Nups in cell type-specific gene
regulation. Findings of this proposal will fill remaining gaps in knowledge regarding the exact mechanisms of
how the NPCs influence binding of chromatin regulatory proteins at different genes, and how this mechanism
influences transcription, peripheral chromatin organization and spatial positioning of genes. We recently
provided new evidence that a particular Nup, NUP153, influences transcription and chromatin structure of
developmentally regulated genes by mediating POL II pausing and binding of chromatin architectural
proteins, CTCF and cohesin, at cis-regulatory elements. Towards dissecting the molecular basis of NUP153-
mediated CTCF binding, we identified the catalytic subunit of the SWI/SNF chromatin remodeling complex,
BRG1, as an NUP153 interacting protein. We hypothesize that the NPC-chromatin interactions through
NUP153 mediate transcription, chromatin structure and peripheral chromatin organization by controlling
BRG1 and CTCF binding. We propose that this mechanism in coordination with POL II pausing is necessary
for cell type-specific gene regulation during early development. We will test this hypothesis by utilizing human
HCT116 cells and mouse embryonic stem (ES) cells and performing genome-wide and genic assays. In Aim
1, we will determine the functional significance of NUP153-BRG1 interactions in NPC-mediated chromatin
structure and transcription. In Aim 2, we will define regulatory function of NPC in spatial chromatin
organization across the lamina. In Aim 3, we will elucidate the functional relevance of NPC-chromatin
interactions in early development. Collectively, findings of this study will provide critical insights into the
functional role for the NPC in integrating transcriptional regulation with chromatin remodeling, and spatial
organization of chromatin, and how POL II pausing and activity participate in these processes during cell
type-specific gene regulation in early development.

Public health relevance
RELEVANCE STATEMENT The way different kinds of cells express various genes at various times and in various amounts is determined largely during early organism development and often relies on proteins known as transcription factors. However, this control of gene expression can also be driven by dynamic interactions between the structures of the nucleus and the structures around the genes – particularly chromatin. Here we will study how nuclear proteins called nucleoporins purposefully link chromatin organization and remodeling to control of gene expression in certain cell types so that we can understand how they function in both health and disease.